BRAIN CONNECTS: An Integrative Connectomics Coordination Center (IC3)

Project Summary
The unique capabilities of mammalian brains arise from their extraordinarily complex network structure, with
billions to trillions of synaptic connections among millions to billions of neurons that form thousands of cell types
and countless functionally specific circuit pathways. Unraveling this network structure, the connectome, holds
the key to understanding how the brain generates behavior, thoughts, emotion and other functions. The newly
launched BRAIN Initiative Connectivity Across Scales (BRAIN CONNECTS) program aims to develop cutting-
edge, highly scalable technology platforms that enable the generation of unprecedented volumes of data in
different and complementary modalities, to create comprehensive brain-wide connectivity maps in mouse, non-
human primate (NHP) and human at different resolutions. These connectivity maps will serve as foundational
resources to the community to dramatically accelerate and transform our understanding of brain functions and
diseases. The Integrative Connectomics Coordination Center (IC3) proposed here will work closely with BRAIN
CONNECTS data generation teams to ensure the successful realization of the program goals. The IC3 brings
together a team of investigators with extensive experience in various connectomics technologies, large-scale
experimental and computational platform development, and consortium management and leadership. We will
coordinate the activities of the BRAIN CONNECTS Network across comprehensive centers and specialized
technology groups. Collaborating with data generation groups, we will develop and harmonize three of the four
common data processing pipelines in the network, including electron microscopy, fluorescence light microscopy,
and barcoded sequencing datasets. We will organize and conduct rigorous evaluation of the technologies for
improved performance and scalability, to enable the next phase of whole-brain scale data generation. We will
develop cloud-based data platforms and analytic tools to facilitate consortium-wide data integration and joint
analysis. We will broadly distribute these tools and products for democratized access and analysis by the
research community. We will establish a BRAIN CONNECTS Knowledge Base (CONNECTS-KB), along with
advanced AI/ML based tools, to incorporate connectivity data into whole brain Common Coordinate Frameworks
(CCFs), achieve integration between molecularly defined cell types and connectivity, and create a unified
representation of brain connectivity across data modalities and across species. We will facilitate the
demonstration of science and health impacts of the BRAIN CONNECTS program to the broad research
community and the general public, through proof-of-concept case studies, online tools allowing external
researchers to access and use the integrated data and connectivity maps, and public-facing outreach and
education activities.

Public health relevance
Project Narrative The uniqueness of mammalian brains lies in their extraordinarily complex network structure, and unraveling this network structure, the connectome, holds the key to understanding how the brain generates behavior, thoughts, emotion and other functions. The proposed Integrative Connectomics Coordination Center (IC3) within the BRAIN CONNECTS network will work closely with the data generation teams in the network to develop cutting- edge, highly scalable technology platforms that enable the generation of unprecedented volumes of data to create comprehensive brain-wide connectivity maps in mouse, non-human primate and human. We will build a BRAIN CONNECTS Knowledge Base (CONNECTS-KB) to broadly disseminate the connectivity maps and associated computational tools as foundational resources to the community to accelerate and transform our understanding of brain functions and diseases.